Demonstrating feasibility of using a robot to deliver a multicomponent intervention to reduce delirium in hospitalized elderly patients living with dementia

ABSTRACT
Delirium, an acute disturbance in attention and cognition and the most common complication
afflicting hospitalized elderly, affects more than 2.6 million U.S. older adults annually. Delirium
associates with greater morbidity, falls, functional decline, nursing effort, daily hospital costs,
hospital length of stay, and nursing home placement; It contributes to more than $164 billion in
annual healthcare costs in the U.S. and accounts for double the mortality in the subsequent
year. People with dementia incur greater risk for incident delirium than the general population,
while delirium itself may forecast or predisposes subsequent development of dementia.
Furthermore, delirium in individuals with dementia can accelerate the trajectory of the underlying
cognitive decline. The adjusted mean difference in costs associated with delirium in ADRD
patients with versus without delirium were $34,828. Patients with a variety of underlying
conditions incur greater delirium risk.
As common as delirium is, 60% of delirium cases remain undiagnosed. At least 30% to 40% of
delirium cases are preventable. We lack convincing, reproducible evidence that any
pharmacological intervention effectively either prevents or treats delirium, while multicomponent
non-pharmacological approaches probably do so by 43%-53% compared to usual hospital care.
These also reduce the risk of falls by 62% among hospitalized non-ICU patients 65 years and
older. The most commonly used multicomponent non-pharmacological methods such as HELP
(Hospital Elder Life Programs) and ABCDEF (in the ICU) are typically administered by nurses,
families or volunteers and are labor intensive. A less labor intensive, scalable approach is
needed.
Robots are increasingly being adopted in healthcare to carry out various tasks that enhance
patient care. The goal of this project is to develop an application that builds personalized
multicomponent non-pharmacological interventions for hospitalized non-ICU elderly patients for
preventing delirium, and to test the feasibility of using an autonomous navigating robot to deliver
the intervention at the bedside. The primary outcome measures will be the percentage of
successful delivery of the non-pharmacological interventions by the robot. Secondary outcomes
will be satisfaction of nurses, patients and families with the robot application.

Public health relevance
NARRATIVE Delirium, defined as an acute disturbance in attention and cognition, affects more than 2.6 million older adults each year in the U.S. with persons living with dementia at higher risk, and associates with increased morbidity, mortality, falls and persistent functional decline. There are no known effective pharmacological interventions, while multicomponent non-pharmacological approaches may reduce incident delirium by 43%-53% compared to usual hospital care but they are labor intensive. The goal of this project is to test the feasibility of using a robot to deliver potentially time-saving personalized multicomponent non-pharmacological interventions to reduce delirium in hospitalized non-ICU elderly patients.